X-RAY CRYSTALLOGRAPHIC &BIOCHEM STUDY OF TATA BOX BINDING PROTEIN &TATA DNA

Characterization of the crystals used for high resolution X-ray crystallographic studies of the TBP/DNA/NC2 ternary complex by MALDI-MS analysis.